CASE-CONTROL STUDY OF PARKINSON'S DISEASE IN THE ELDERLY

We will investigate changes in iron metabolism and caloric intake in Parkinson's Disease over time in early untreated or recently treated patients (n=200) and late PD (n=100). We will also characterize and determine the frequency of altered forms of mitochondrialaconitase in PD and controls.